SAFETY, TOLERANCE &INFLUENCE ON CLINICAL STATUS OF RO-19-6327 IN PARKINSONISM

The aim of this work is to evaluate the safety, tolerability, and efficacy of this monoamine oxidase inhibitor as therapy in early Parkinson's disease.